Engagement and outreach to achieve a FAIR data ecosystem for the BICAN

As a part of BRAIN 2.0, the BRAIN Initiative Cell Atlas Network (BICAN) is expected to advance fundamental knowledge and enabling technology for classifying human brain cell types, understanding their organizational principles, and providing open-access digital brain cell reference atlases, emphasizing cell diversity in health and disease. Undertaking the grand challenge of BRAIN 2.0 requires the scientific community to collaborate and tap the tremendous skill and knowledge in a diverse set of disciplines outside of neuroscience. BICAN's Coordinating Unit for Biostatistics, Informatics, and Engagement (CUBIE) is designed to provide effective coordination benefits to the awardee network, the NIH, and the scientific community. Advancing the ambitious BICAN goals requires CUBIE to anticipate and address potential challenges in coordinating time-sensitive management activities, mitigating data complexity and tool scalability, and supporting diverse service needs. Our team is highly experienced in leading large consortia projects at national scale, such as RADx-rad Data Coordinating Center, bioCADDIE data discovery project, informatics cores for the CTSA, the national neurological data resources. We have the knowledge, skill set, and resources to launch the Engagement and Outreach element for CUBIE (CUBIE4) and work with the BICAN network in taming the structural and organizational complexity of data and driving a FAIR (Findable, Accessible, Interoperable, Reusable) data ecosystem through three facets. The Administration Facet will ensure effective communications among the awardees to maximize synergy, facilitate collaboration and resource utilization across the BRAIN Initiative. We will provide support and establish processes for network members to adhere to data models, terminology standards, data formats and structures, conforming to FAIR data principles. We will launch, maintain and enhance a Web Portal and a Data Dashboard for the BICAN network, using role-based access control and a cutting-edge content-management system. The Technology Facet will work with other CUBIE elements and BICAN network awardees to establish metadata standards for diverse brain data; apply best practices related to data interpretability and integrability; and develop a cloud-based technology testing platform to provide sandboxes for exploring, evaluating and iteratively improving tools developed through BICAN. The Service Facet will assist BICAN awardees in their development of data processing and analytics (including machine learning) tools to ensure that they are portable, scalable, and user-friendly. In particular, our biostatistics team will provide data rendering and analytics support to provide informed and timely feedback to CUBIE and the BICAN stakeholders. We contribute to diversity in multidisciplinary knowledge, women and early-career investigators, neurological diseases and brain health perspectives, and institutional inclusivity resources. Therefore, the CUBIE4 team is uniquely well-positioned to advance the overarching goals of BICAN.

Public health relevance
BICAN's Coordinating Unit for Biostatistics, Informatics, and Engagement (CUBIE) is designed to provide effective coordination benefits to the awardee network, the NIH, and the scientific community. Advancing the ambitious BICAN goals requires CUBIE to anticipate and address potential challenges in coordinating time-sensitive management activities, mitigating data complexity and tool scalability, and supporting diverse service needs. Our CUBIE coordination and outreach team is highly experienced in leading large consortia projects at national scale, unique in bringing a set of diverse perspectives, and well-positioned to advance the overarching goals of BICAN.